Development of optimal sensory feedback strategies to maximize function after tetraplegia

Our goal is to develop and optimize novel neurostimulation strategies to restore intuitive and informative
somatosensation to people with tetraplegia. Sensory feedback is critical for regulating dexterous grasp during
activities of daily living and for emotional connection with loved ones. Neuroprostheses to restore voluntary
control of reaching and grasping to users with paralysis will be more likely to achieve clinically-meaningful
benefits in independence and quality of life if sensory feedback is integrated into these systems. The central
hypothesis is that restoring sensation with intracortical microstimulation (ICMS) of primary somatosensory cortex
and/or peripheral nerve stimulation (PNS) will improve performance of brain-controlled grasp tasks. The
secondary hypothesis is that paired ICMS and PNS will promote neuroplasticity and enable users to recover
some of the below-injury sensory function lost due to spinal cord injury. Three participants with chronic tetraplegia
enrolled in an existing clinical trial who have already received chronically-implanted cortical arrays and nerve
cuff electrodes will participate in the proposed study. The study has three specific aims: 1) Determine the impact
of spatiotemporal ICMS paradigms on perception and function. Novel ICMS encoding schemes that prioritize
different neural coding properties and information content of the transmitted touch stimuli will be developed and
compared. The perceptual response to each ICMS paradigm will be evaluated with classical psychophysical
techniques. Decoders that map cortical activity to desired hand/arm movement commands will be developed
and used to perform grasp tasks in virtual reality. The functional utility of each ICMS paradigm will be evaluated
and compared. 2) Determine the impact of spatiotemporal PNS paradigms on perception and function. Novel
PNS encoding schemes will be developed and their impacts on perception and brain-controlled task performance
will be compared. The effect of a PNS training paradigm on below-injury sensory function will also be evaluated.
3) Determine the impact of hybrid (ICMS+PNS) neurostimulation on perception and function. Novel hybrid
stimulation paradigms will be developed through systematic investigations of percept integration resulting from
manipulations of encoding scheme, electrode contacts, and inter-stimulus timing. Hybrid stimulation will be
compared to ICMS-only and PNS-only paradigms in both perceptual characteristics and virtual task performance
gains. The effect of a hybrid neurostimulation training paradigm on recovery of below-injury sensory function will
also be evaluated. The proposed work will improve our understanding of the perception of neurostimulation
applied throughout the sensory nervous system, the benefits of restored sensation on the functional utility of
brain-controlled neuroprostheses, and the role of touch information content in these outcomes. This study will
also determine the feasibility of a future therapeutic intervention using neurostimulation for below-injury sensory
recovery. Study findings have implications for the future development and translation of neuroprostheses to
restore sensorimotor function to people with tetraplegia.

Public health relevance
This project will develop and optimize novel strategies of somatosensory restoration for people with tetraplegia due to spinal cord injury. These novel strategies aim to increase the naturalness and usefulness of the restored sensation, improve hand grasp function provided by cortical neuroprostheses, and enable users to recover some of the below-injury sensation lost due to spinal cord injury. Findings will advance our understanding of the perceptual and functional impacts of sensory neurostimulation and will ultimately lead to the clinical translation of neuroprosthetic technologies to increase the independence and quality of life of people with tetraplegia.